Supplement: Pathophysiology of DYT1 dystonia: Targeted Mouse Models

This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-RM-
24-013. Dystonia is a movement disorder characterized by sustained or intermittent muscle contractions
causing abnormal, often repetitive, movements or postures. DYT1 early-onset generalized dystonia is the most
common type among genetic dystonias. Most of the individuals affected by DYT1 dystonia share a trinucleotide
deletion (ΔGAG) located in exon 5 of DYT1 or TOR1A gene, leading to a loss of a glutamate amino acid
residue for torsinA (torsinA∆E). The symptoms start in the limbs and then become generalized. Affected
individuals could be seriously disabled and need to use a wheelchair. Conditional knockout of torsinA and
knockin of mutant torsinA in mice points to the involvement of multiple brain regions and cell types in the
pathogenesis of DYT1 dystonia. So far, these and other pathophysiological studies of DYT1 and other
dystonias support a circuit or network model of dystonia pathogenesis. However, which brain region and
neuronal types play a critical role in pathogenesis is unclear. Preliminary studies of conditional knockin (KI)
mouse models of DYT1 dystonia revealed striatal medium spiny neurons (MSNs) play a vital role in the
pathogenesis of DYT1 dystonia. However, how torsinA∆E in MSNs leads to dystonia is unknown. These
unknowns impede the development of effective treatment for DYT1 patients. The broad, long-term
objective is 1) to determine the functional role of torsinA in vivo and the mechanism by which torsinA∆E
leads to DYT1 dystonia, 2) to develop a novel and effective treatment. The specific goal of this
supplement application is to replicate the behavioral analysis of a newly developed, targeted DYT1
mouse model with an overt dystonia phenotype without growth retardation and use this model to test its
suitability for preclinical drug development (part of the original Aim 1). We hypothesize that additional
ΔGAG expression in the striatal MSNs in Dyt1 KI mice will accelerate the development of the dystonia
phenotype in mice and better recapitulate the phenotype of human dystonia for pathophysiological studies
and preclinical drug testing. We plan to collaborate with NIH-assigned CRO to replicate the newly
developed novel overt dystonia model. We will generate and characterize this conditional KI line in the
heterozygous Dyt1 ΔGAG KI background. We will perform the tail suspension test to determine the overt
dystonia phenotype and the treatment effect of trihexyphenidyl, an FDA-approved drug for dystonia
patients. We are particularly well prepared to undertake the proposed research because we have
developed and characterized the novel Dyt1 conditional KI mice. The successful completion of the
proposed study will characterize and validate a novel DYT1 dystonia mouse model that will contribute
significantly to the study of the pathophysiology of DYT1 dystonia and the development of anti-dystonia
drug treatment. It will also have an impact on other dystonias and related neurological disorders.

Public health relevance
Close to 500,000 Americans have dystonia, representing the third most common movement disorder after Parkinson’s disease and tremor. We will use molecular genetics, electrophysiology, and behavior analysis to determine protein function in specific cells and to gain a basic understanding of how cell-specific changes lead to dystonia-related motor deficits.